Deciphering Inflammatory Regulation of Oral Epithelial Progenitor Cells During Oral Mucosal Regeneration

Project Summary
The oral cavity represents a unique healing environment that is relatively unexplored. Regeneration within the
oral mucosa occurs rapidly, with wounds closing at four times the rate of the skin, and the inflammatory reaction
to wounding is relatively suppressed. Chronic wounds within the oral cavity compromise the ability of patients to
obtain nutrition and are prone to debilitating infections, thus constituting an important oral health problem.
Understanding how the oral mucosa is able to achieve such regeneration, and therefore how wound healing is
disrupted in disease environments, would be a significant achievement for the field of craniofacial research. The
specific cellular mechanisms used by the oral mucosa to facilitate its distinct regenerative phenotype remain
elusive and are addressed in this proposal.
Studies comparing dermal and oral wounds have shown that oral wound healing displays a short
inflammatory phase followed by a rapid transition into wound closure via epithelial cell proliferation, migration
and differentiation. Chronic inflammation in the oral cavity is the cause of many pathologies, such as periodontitis,
oral mucositis and osteonecrosis of the jaw, but how inflammation leads to epithelial atrophy or lingering open
wounds in the oral mucosa is unknown. Given that the oral epithelial progenitor cell (OEPC) population mediates
re-epithelialization, this proposal will test the hypothesis that inflammation acts as an important coordinator of
wound closure and re-epithelialization via direct regulation of the OEPC population. Wound healing will be
assessed in animals under three inflammatory states: normal, low and high. The effects of attenuated and
exacerbated inflammation on regeneration will be established by scoring for time to wound closure, epithelial
layer integrity and proliferation and apoptosis within the entire tissue (Aim 1). Next, the cellular and molecular
mechanisms of inflammatory regulation on the OEPC population will be determined using single cell RNA
sequencing under the three conditions, and direct regulation of the epithelium by the immune system tested
using an in vitro co-culture system (Aim 2). Data from these aims will determine how inflammation regulates
wound closure and elucidate key mechanisms through which inflammation influences re-epithelialization, which
will yield valuable insights into the mechanisms of wound closure within the oral mucosa.
These research goals will be conducted in conjunction with a comprehensive training plan designed to
develop the applicant’s career as a dentist-scientist. The training includes structured mentorship from two highly
qualified clinician-scientist sponsors, and scientific and technical training through individual and group meetings,
seminars, journal clubs, classes and departmental events. Research and training will take place at the University
of California, San Francisco, which offers both an outstanding research environment and an excellent dental
school for clinical training.

Public health relevance
Project Narrative Although the unique regenerative potential of the oral mucosa has long been recognized and appreciated, the mechanisms that facilitate rapid wound closure, limited inflammatory response and the non-scarring phenotype of the oral cavity are unknown. This proposal will build off our lab’s preliminary characterization of the oral epithelial progenitor cell (OEPC) population to dissect how low and high inflammatory conditions can alter OEPC response to injury and the ability of the oral mucosa to heal. This work acts as a necessary first step in understanding the superior regenerative capacity of the oral mucosa and the regulatory ability of inflammation, which will aid in our understanding of chronic inflammatory diseases in the oral cavity and facilitate the development of therapies that harness the innate mechanisms of the oral mucosa to improve or stimulate wound healing.